Post-mortem MRI for improving the diagnosis of Alzheimer’s mimics in the oldest old

The oldest old, people aged 90 years or older, are the fastest growing segment of the worldwide
population with a staggering increase in the prevalence of dementia. Unlike younger groups, Alzheimer’s disease
neuropathology (ADNP) is no longer the most dominant degenerative neuropathology in the oldest old and
dementia is often due to the presence of multiple neuropathologies. Hippocampal sclerosis (HS) and small vessel
lesions (SVL) are important contributors to dementia in the oldest old. Due to lack of reliable biomarkers, HS
remains undetected and SVLs are under-recognized during life. These limitations hamper efforts in developing
target-specific therapeutics. The long-term goal of this project is to improve the in vivo diagnosis of these
important pathologies using insights gained from postmortem brain MRI. Compared with MRIs acquired during
life, postmortem MRI has the ability to acquire significantly higher quality scans allowing for better quantification
and localization of abnormalities of brain tissue.
The 90+ Study, a longitudinal observational study of participants aged 90 years or older at the University
of California, Irvine, provides a unique opportunity to examine the utility of postmortem brain MRI in the oldest
old. Neuropathological assessments are currently being conducted on the donated brains and a considerable
subset of participants will have undergone brain MRI during life allowing for comparisons between in vivo and
postmortem imaging findings and translation of the insights gained from postmortem to in vivo MRIs. We have
already developed the sequences and started acquisition of postmortem MRI scans proving the feasibility of our
approach. We anticipate acquiring postmortem MRI scans for 50 participants and based on our current data, this
sample will provide sufficient number of cases harboring the two pathologies of interest i.e. HS and SVLs.
Moreover, our power calculations indicate that we will be able to test the hypotheses of this proposal with this
sample size.
In aim 1, we will test the hypothesis that hippocampal sclerosis will be associated with MRI detectable volume
loss and signal change in the hippocampus and that postmortem MRI has a higher sensitivity to detect these
compared with MRI acquired during life. In aim 2, we will test the hypothesis that postmortem MRI allows for
detection of higher numbers of SVLs when compared with MRI acquired during life.
At completion of this work and utilizing the insights gained from this study, we will apply for an R01 grant
to prospectively study the utility of post-mortem MRI in prediction of hippocampal sclerosis and SVLs in a large
cohort. The insights gained from these studies will be used to enable prediction of HS and improve the detection
of SVLs in MRIs acquired during life. This will subsequently enable development of targeted therapies against
these two important pathologies that significantly contribute to development of dementia in fastest growing
segment of our population that will represent half of all of those suffering from dementia by 2050.

Public health relevance
Narrative The proposed research is relevant to public health because its ultimate goal is to enable the diagnosis of two important dementia related pathologies in the oldest old individuals namely hippocampal sclerosis of aging and small vessel lesions. People aged 90 and older are the fastest growing segment of the population and have the highest rates of dementia. Ability to diagnose these pathologies during life will allow for development of therapies and reduce the burden of dementia.